Exploring cyclic di-nucleotide signaling across the tree of life

Scope of Work
This administrative supplement will support Dr. Nkrumah Grant for a postdoctoral position in
the Waters laboratory at Michigan State University. Dr. Grant will perform research to
understand the function of novel Vibrio cholerae phage defense systems in their ecological
context and explore if these systems can spread in bacteria populations through horizontal
gene transfer. The research will expand the molecular biology skills of Dr. Grant, building upon
his expertise in experimental evolution, to position him for his own future faculty position.
While at MSU, Dr. Grant will be supported by Dr. Waters, his laboratory, and many mentoring
and career development programs available to postdoctoral research fellows.

Public health relevance
Project Narrative Cyclic di-nucleotides are central second messenger signaling molecules that allow living systems to connect changes in their external environment to regulation of adaptive behaviors. This proposal will address fundamental questions about cyclic di-nucleotide signaling in both prokaryotic and eukaryotic organisms.